DOUBLE BLIND STUDY OF RHIL-11 IN SUBJECTS WITH POSITIVE CROHN'S DISEASE

The purpose of this study is to assess the safety and tolerability of Recombinant Human Interleukin Eleven at varying doses, as compared to placebo, in subjects with active Crohn's Disease.